Role of intestinal serotonin transporter in post traumatic stress disorder

Post traumatic stress disorder (PTSD) a devastating psychiatric disorder and one of the most difficult service-
related disabilities in Veterans, nonetheless without a consistently effective therapy. The only FDA-approved
drugs for the treatment of PTSD are the selective serotonin reuptake inhibitors (SSRIs); the response rate to
these drugs, however, is relatively small requiring development of more specific and individually effective
therapies. In this regard, the neurotransmitter and hormone, serotonin (5-HT) is well-recognized for its role in
depression, anxiety, aggression, impulsivity, and suicidal behaviors, which are frequently found in PTSD
patients. Serotonin transporter, (SERT; SLC6A4), regulates the extracellular availability of 5-HT, and is a
common target for SSRIs. Linkage of the short allele of the SERT gene polymorphism has been implicated in
increasing the vulnerability to develop PTSD and predicting poor treatment outcome. In this regard, SERT is
abundantly expressed in the gut and its dysfunction has been shown to cause gut microbiota alterations; albeit
its role in the predisposition or progression of PTSD is not fully understood. To gain insights into the role of gut-
microbiota and SERT interactions in PTSD, we utilized our recently developed novel transgenic model with
inducible overexpression of SERT restricted to intestinal epithelial cells (SOEIEC) that exhibits low fecal 5-HT
levels (LC/MS). The mouse model of protracted social isolation (SI), was used as chronic stressor important to
elicit PTSD-like increased aggression in resident intruder assays. Interestingly, males with SOEIEC under SI
exhibited increase in aggression while females were resilient as compared to wild type counterparts. To
understand the sex-dependent differences, we correlated the aggression with structure of gut microbial
communities. The data demonstrated a strong negative association of aggression with genus Desulfovibrio
(sulfate reducing bacteria) and positive associations with Bacteroidales, Gastranaerophilales, and genus-
Anaerotruncus. How 5-HT pools in the gut impact upstream factors affecting gut microbiota and triggers
downstream factors in the gut and brain leading to PTSD like behavior in a sex-dependent manner is not known.
Thus, our proposed studies will use cell specific SOE (in IEC and in neurons) to further elucidate PTSD related
fear conditioning responses and aggression behavior and elucidate the underlying molecular mechanisms
across gut-brain axis (Aim 1). Additional studies utilizing SOE and SERT KO are needed to assess the causal
role of SERT induced gut-microbiota changes in predisposing mice (M/F) to fear deficits/increased aggression
(Aim 2). This will be achieved by fecal microbial transplant and assessing the functional role of gut microbial
changes by integrating the PTSD-like behavior with downstream targets (single cell RNA seq) and selected
metabolites along gut-brain axis. The outcome of the studies will provide novel insights into the role of intestinal
SERT in PTSD predisposition and will pave the way for microbial based therapeutics for PTSD management.

Public health relevance
Narrative: PTSD is a stress and trauma related psychiatric illness that poses significant health burden. The medications for PTSD include SSRIs which are not effective in all Veterans and have a variable response rate warranting newer treatment options. Now it is increasingly recognized that our guts play important role in controlling brain function. Our laboratory made a novel mouse model where intestinal SERT, target of SSRI, can be increased in the gut without increasing brain SERT. Our exciting data showed that this mouse model with higher SERT in intestine showed severe aggression behavior under traumatic stress in the males, but the females with higher SERT showed resilience. The aggressive responses were correlated with gut bacteria. For example, higher aggression in males showed less H2S producing Desulfovibrio bacteria among other alterations. We will undertake extensive studies to understand how intestinal SERT affects gut microbiota brain axis to cause PTSD, so that microbes based medications can be individualized for more effective management of PTSD in both sexes.